Research Resources: Epigenomic and Transcriptomic Profile of Human Immune Cells

PROJECT SUMMARY
While an enormous number of genetic variants have been associated with risk for human disease, how these
variants affect gene expression in various cell types remains largely unknown. To address this gap as it relates
to immune cells, as well as to identify which immune cell types are most susceptible to the effects of disease-
risk variants, the DICE (Database of Immune Cell Expression, Expression quantitative trait loci (eQTLs) and
Epigenomics) project was funded by the current R24 resource grant (R24AI108564). Although several
autoimmune diseases like Systemic lupus erythematosus (SLE), display severe clinical manifestations in
patients of Hispanic/Latino, Asian and African ancestry, the genetic risk factors that influence disease
mechanisms have not been extensively studied, largely due to the exclusive focus of the initial genome-wide
association studies (GWAS) on individuals of European ancestry. However, recent multi-ancestry GWAS meta-
analyses that included individuals of diverse ancestries have identified many ancestry-specific disease-risk
variants. To translate the biological significance of these GWAS-led discoveries in under-represented
populations, high-resolution eQTL studies in immune cell types from individuals of diverse ancestries are
needed to define the effects of disease-risk variants. While the current DICE cohort is more diverse (46%
Europeans) compared to other large-scale eQTL studies, there remains a need to include equal representation
from other globally prevalent ancestral populations. In Aim 1, we will generate transcriptomic and eQTL
reference data in common and rare circulating immune cell types from equal numbers of male and female
individuals of Hispanic/Latino, African, East Asian, South Asian and European ancestries (n=350;
n=70/ancestral group) – DICE-Diversity resource project. We will perform single-cell RNA-seq in flow-sorted
immune cell types and conduct single-cell-eQTL mapping to test associations between variants and gene
expression. In Aim 2, we will define genes and cell types associated with autoimmune diseases in diverse
populations, including minorities. To accomplish this objective, we will perform TWAS and colocalization
analysis to integrate published multi-ancestry GWAS in autoimmune disease and eQTL datasets in immune
cell types generated in this DICE-Diversity project. In Aim 3, we will make DICE data accessible and visible to
the broader scientific community. We will expand our existing website to make current and newly generated
experimental data and analysis tools available to the community. Overall, the renewal of the DICE project will
greatly enrich this dataset with descriptions from individuals of different ancestries. The new DICE-Diversity
database of transcriptomic and eQTL data for the human immune system should also facilitate mechanistic
and functional investigations into the role of disease-risk variants emerging from multi-ancestry GWAS studies
and eventually benefit health outcomes in diverse populations, including minorities.

Public health relevance
PROJECT NARRATIVE/RELEVANCE For many human diseases, large-scale genomic studies have identified common genetic variants that occur more frequently in people with cardiovascular, autoimmune, inflammatory and infectious diseases, diabetes and asthma than in those without these diseases. Here we propose to understand how these genetic variants cause susceptibility to immune-mediated diseases in diverse populations, and use this information to find novel therapeutic targets for these diseases.